SEER-LINKED PEDIATRIC CANCER WHOLE SLIDE IMAGING

Project Abstract: This pilot project is designed to assess the feasibility of obtaining whole slide images (WSI) of microscopic slides that were generated as part of cancer diagnosis and surgical treatment. The pilot project also seeks to establish a set of best practices for obtaining WSI and corresponding cancer case information. Further, the New Mexico Tumor Registry’s area of coverage affords a unique opportunity to implement and assess the SEER-Linked Pediatric Cancer Whole Slide Imaging Pilot in a population that is highly diverse with regard to race/ethnicity, socioeconomic status, and urban/rural residence.